Training Program in Translational Cardiovascular Research and Entrepreneurship

Abstract
This renewal proposal seeks continued funding for the Training program in Translational Cardiovascular
Research and Entrepreneurship (CVRE) at the University of Michigan. Cardiovascular disease is the leading
cause of death worldwide. The mission of this program is to train the next generation of PhD scientists seeking
careers in cardiovascular research in the ethical development and application of research results from the
laboratory to the bedside, with the ultimate goal of improving therapy for patients. The proposed training
program is intentionally designed to address the gap in training of young basic scientists and pre-doctoral
students in key areas of translational cardiovascular research such as preclinical research design, drug
discovery, device/therapy development, optimization and testing, research entrepreneurship, and regulatory
compliance. The interdisciplinary and internationally recognized faculty of this program provides an
outstanding training environment that includes state of the art facilities and techniques spanning genetic,
molecular, cellular, systems, engineering and clinical investigation of both vascular and cardiac diseases. By
capitalizing on the existing strengths of our faculty in basic, preclinical, and translational cardiovascular
research, and unique academic resources at the University of Michigan, we will train students not only in state
of the art biomedical research, but also in applying systems biology for preclinical testing, navigating regulatory
compliance, and the process and challenges of research entrepreneurship. Therefore, this program offers
students a unique comprehensive and immersive educational experience in translational research training.
The added benefit is that the program will also prepare students for the diversity of scientific careers available
to and often pursued by young scientists including academic research, start-up companies, biotechnology and
large pharmaceutical and device companies. The Translational CVRE program will attract trainees at the PhD
Candidate level from laboratories across the Frankel Cardiovascular Center faculty membership, from
exceptionally strong graduate programs in the medical school wide Program in Biomedical Sciences, and the
College of Engineering and School of Pharmacy. Funds are requested for 5 trainee slots per year, and
students may be reappointed for a second year by competitive renewal. The key program features are 1)
strong, fundamental basic research training on translationally relevant research topics under the
NHLBI mission 2) training in preclinical research design and phenotypic testing 3) didactic and
experiential learning on research entrepreneurship along with career path relevant skills
development. By placing students at the interface between basic cardiovascular research, biomedical
engineering, and cardiovascular medicine, we hope to better prepare the next generation of PhD scientists to
be leaders at taking basic research discoveries and being capable of directing their path to the clinic.

Public health relevance
Narrative Cardiovascular disease is the leading cause of death worldwide. The Translational Cardiovascular Research and Entrepreneurship Training Program is focused on training the next generation of PhD scientists to be capable of both making discoveries in the molecular mechanisms of cardiovascular disease and leading research programs to guide the translation of those discoveries into effective therapies that can be applied in clinical medicine. This training program will therefore contribute to accelerating the translation of laboratory discoveries into clinical therapies that directly impact our ability to improve treatment of human cardiovascular disease.